The role of homeobox transcription factor Nkx2.1 in nervous system development

Project Summary
Attention Deficit/Hyperactivity Disorder (ADHD) affects almost 5% of children and persists into 2.5% of adults.
There is a strong genetic component to ADHD. For example, heterozygosity in the homeobox transcription factor
Nkx2.1 causes a syndromic variant of ADHD, which is frequently associated with autism-like symptoms. In
addition, mutations in RFX family transcription factors cause autosomal dominant ADHD with concomitant autism
spectrum disorder symptoms in many cases. Expanding on this, recent Genome-Wide Association Studies and
meta-analyses identified 27 ADHD-associated loci. Of these genes, one third were associated with gene
transcription in some way, either as transcription factors, transcriptional co-regulators, RNA splicing factors,
transcription terminators, or histone modification enzymes. These data strongly implicate defects in gene
regulation as underlying these highly prevalent neurological conditions, and point to their polygenic nature. This
brings up a question; how do these multiple ADHD and ASD associated genes relate to each other and how
does that impact the neurological disorder in question?
Transcription factors frequently function in cascades, with one factor switching on the gene expression of another
transcription factor, etc. to ultimately define the battery of genes expressed in a terminal fate cell. Many
transcription factors, including Nkx2.1, are deeply conserved across species. This allows us to examine
transcription factor function in genetically tractable model organisms such as nematodes and flies. This proposal
aims to take advantage of this, using the nematode Caenorhabditis elegans to investigate Nkx2.1 function during
nervous system development. C. elegans has an invariant cell lineage, making it ideal for investigating questions
of cell fate specification and function. In addition, there are powerful genetic tools available to aid investigation.
Finally, C. elegans is a transparent organism, so individual neurons can be highlighted using genetically encoded
reporter genes such as green fluorescent protein. C. elegans contains a single Nkx2.1 ortholog, ceh-27. Our
preliminary data reveals that ceh-27 null mutations are 100% embryonic lethal, showing that this gene is
absolutely required for normal embryonic development. The proposed studies will 1) investigate ceh-27’s role in
cell fate specification during nervous system development; 2) investigate its relationship with other proneural
transcription factors such as ngn-1/neurogenin; and 3) use state-of-the-art single-cell RNA sequencing
approaches to identify ceh-27 downstream targets. The high sequence conservation of ceh-27 across species
means that our data can be used to investigate human orthologs of C. elegans ceh-27/Nkx2.1 targets, to better
understand their roles in neurological disorders such ADHD and ASD. This project directly addresses
fundamental mechanisms of nervous system development and gene regulation. In addition, the proposed
experiments are technically straight forward and are comfortably within the grasp of undergraduate and master’s
students. As such, this project will accomplish both broad and specific AREA program goals, including enhancing
Kennesaw State University’s research environment and exposing students to high quality research through direct
participation.
PHS 398/2590 (Rev. 11/07) Page 1 Continuation Format Page

Public health relevance
Public health relevance statement Genetic studies have implicated the transcription factor Nkx2.1 in attention deficit hyperactivity disorder (ADHD) and learning difficulties, although little is known about how mutations in this gene affect nervous system development and function. Using the nematode Caenorhabditis elegans as a model for these studies, we aim to identify downstream transcriptional targets of Nkx2.1. This gene is highly conserved from worms to humans, so the gene regulatory network defined in our Nkx2.1 worm model will be translatable to understanding how a known ADHD-associated gene functions in humans. PHS 398/2590 (Rev. 11/07) Page 1 Continuation Format Page